XCSITE 300: Cloud-Enabled Closed-Loop Transcranial Current Stimulation Device for At-Home Studies

PROJECT SUMMARY – Pulvinar Neuro LLC, TOWNSEND
The causal role of circuit activity dynamics in depression remains poorly understood due to the lack of tools for
non-invasive, targeted circuit modulation. Today’s non-invasive brain stimulation approaches apply generic
stimulation waveforms without targeting individual activity signatures and without dynamically adapting
stimulation to ongoing fluctuations in brain activity. To address this gap, the long-term goal of Pulvinar Neuro is
to develop, evaluate, and commercialize targeted closed-loop transcranial alternating current stimulation (tACS)
technology, which measures brain activity with EEG and dynamically applies weak rhythmic electric fields to
modulate network oscillations. In the previous Phase 1 SBIR, Pulvinar Neuro developed XCSITE 100Pro, a
closed-loop tACS device that was successfully tested for feasibility in healthy human participants, and XCSITE
200, a cloud-based platform for remote stimulation. The overall goal of this application is to develop and evaluate
the XCSITE 300 platform that will integrate closed-loop capabilities with cloud-based stimulation and study
management. The rationale for this project is that such a solution will drive the next generation of circuit-based
research in psychiatry and that closed-loop tACS has the potential to become a safe and effective treatment for
depression given the initial positive findings of open-loop tACS for the treatment of depression and the substantial
unmet market need. Three specific aims will be pursued to accomplish this goal. (1) Integrate and bench test
closed-loop tACS technology with cloud-based infrastructure, (2) Test XCSITE 300 for in-lab use in a pilot
double-blind single-site study for the treatment of depression (XCSITE 300 Clinic), and (3) Adapt device form
factor and user interface for at-home use (XCSITE 300 Home) and establish feasibility in a pilot study in people
with depression. At completion of the proposed work, feasibility and preliminary efficacy of closed-loop tACS will
be established and closed-loop tACS for use in a clinic and for at-home use by patients will be ready for pivotal
studies for the treatment of depression. The work in this application is innovative given the lack of available
cloud-enabled (“smart”) closed-loop tACS devices for probing circuit dynamics and for evaluation of clinical
efficacy in rigorous double-blind trials. The proposed work is significant since closed-loop tACS will enable the
investigation of the causal role of specific circuit dynamics in humans and the development of novel treatments
for depression which are urgently needed.

Public health relevance
PROJECT NARRATIVE – Pulvinar Neuro LLC, TOWNSEND Transcranial current stimulation (TCS) is a non-invasive form of brain stimulation that is being studied as a treatment for several psychiatric disorders, including depression and schizophrenia. This proposal develops XCSITE 300, a cloud-enabled TCS device that delivers individualized closed-loop stimulation and can be used in large double-blind placebo-controlled studies either in a clinic or research laboratory (XCSITE 300 Clinic) or at-home (XCSITE 300 Home). This work is of impact in human health because it is a key step towards novel brain stimulation treatments for mental illness, including depression.